Characterizing the functions of a putative DNA N6-adenine methylation demethylase AtALKBH4 in plants

The long-term goal of this research is to understand the function and mechanism of DNA N6-adenine
methylation (6mA) and its demethylases in gene regulation in eukaryotes. Epigenetics has attracted many
research efforts in the last two decades due to its importance in regulating many processes in cells, as well
as the growth and development of plants and mammals. DNA methylation on the fifth position of cytosine
(5mC) is an abundant and essential epigenetic mark in both plants and mammals. However, DNA 6mA is
relatively rare in eukaryotes, and the existence and functions of 6mA in eukaryotes remain controversial.
With recent progress in next-generation sequencing technology and mass spectrometry, it has been shown
that 6mA plays a critical role in regulating gene expression in eukaryotes. Furthermore, little is currently
known about 6mA demethylases in eukaryotes, which remove the methyl group from 6mA residues. We
have found an E. coli alkylation B homolog 4 (ALKBH4) gene in Arabidopsis (AtALKBH4) that can serve as
a 6mA demethylase in vivo. Here, I propose to 1) Measure DNA 6mA levels in the Atalkbh4 mutant and
AtALKBH4 overexpression transgenic plants, as well as map the genomic locations of DNA 6mA in plants. I
propose to use an ultra-high-performance liquid chromatography-triple-quadrupole mass spectrometer-
mass spectrometer (UHPLC-QQQ-MS/MS) to measure 6mA levels in the Atalkbh4 mutant and AtALKBH4
overexpression transgenic plants. We will also use Single Molecule, Real-Time (SMRT) sequencing
technology to determine the genomic locations of 6mA in Arabidopsis. 2) Analyze the enzymatic activities of
the putative 6mA demethylase AtALKBH4 in vivo and in vitro. We will mutate the conserved residues of
AtALKBH4 and transform the mutated constructs into the Atalkbh4 mutant plant to examine AtALKBH4
activities in vivo. We will also express and purify AtALKBH4 proteins and incubate them with putative DNA
substrates to determine AtALKBH4 demethylase activities in vitro. 3) Determine the function of the
AtALKBH4 gene in Arabidopsis. We will examine vegetative and reproductive phenotypes of the Atalkbh4
mutant and AtALKBH4 overexpression transgenic plants under normal and stress conditions in comparison
to the wild-type plants. This study is significant because it responds to recent calls for the reassessment of
the existence of 6mA in eukaryotes, and will determine the function and enzyme activities of a putative 6mA
demethylase in plants. This research is innovative because it employs novel approaches to overcome
previous limitations in addressing 6mA existence and functionality in eukaryotes. These approaches include
using plants grown on sterile mediums without soil bacterial contamination,
UHPLC-QQQ-MS/MS,
and
SMRT sequencing technology. To achieve the above specific aims, this research will employ genetic,
molecular, biochemical, and genomic approaches, revealing the enzymatic activities and functions of the
DNA 6mA demethylase AtALKBH4 in plants.

Public health relevance
The proposed project will use Arabidopsis, a model plant system, to determine the function and enzyme activities of the putative 6mA demethylase AtALKBH4 by employing genetic, molecular, biochemical, and genomic approaches. The epigenetic processes are evolutionarily conserved in mammals and plants and integral to the pathology of human diseases, such as cancer. Knowledge about the function and regulation of 6mA and its demethylases will provide valuable insights for understanding the causes of abnormal 6mA methylation associated with the onset and progression of cancer.